Synaptic Mechanisms in the Auditory System

Summary
This research will examine the synaptic and circuit-level properties of neurons of the mouse cochlear nucleus
in vitro, based on recent work that defined cell types through transcriptomic profiles. Major cell types will be
recorded from using patch clamp techniques monitoring the properties of their axonal projections, synaptic
input from auditory nerve, and intrinsic properties and then correlate these with the cells individual
transcriptomic profile using Patch-seq. This will provide new functional insight into the diversity within major
classes of cells in cochlear nucleus. Next, we will use mouse cre lines to drive expression of optogenetic tools
in order to resolve functional differences in the connectivity and inhibitory synapses of different classes of
interneuron. Last, we will optogenetically activate specific populations of principal cell while recording from
single principal cells in order to examine homotypic synaptic connections among principal cells. These results
will provide unprecedented insight into the capacity of neurons in the cochlear nucleus to perform
computations on incoming sensory signals. Moreover the results will provide a foundation for future studies
examining how these computations are distorted with hearing impairment.

Public health relevance
Relevance This study builds on new research into the functional significance of neuronal cell types in the mammalian cochlear nucleus, the first station for auditory processing. The results are essential for eventually understanding how the brain changes following injury or disease that affects hearing. This is important as such brain changes can affect speech processing and the effectiveness of hearing devices like hearing aids and cochlear implants.